NOX Family NADPH Oxidases GRC/GRS

Project Summary
The Gordon Research Conference (GRC) and Seminar (GRS) on NOX Family NADPH Oxidases is scheduled
for May 28 - June 3, 2022, at the Mount Snow Resort, VT, USA. The NOX GRC will feature unpublished cutting-
edge work from international experts as well as emerging early-career investigators in this field. The preceding
NOX GRS (May 28-29, 2022) will address specific interests and needs of young research trainees, graduate
students and post-doctoral fellows, and will include mentoring sessions addressing career opportunities,
grantmanship, etc. NOX enzymes are present in all cell types and are major sources of cellular production of
reactive oxygen species, and this enzyme family is increasingly implicated in diverse physiological processes,
as well as in many disease types. The NOX research field is advancing rapidly with exciting new developments
in NOX biochemistry and structural biology, mechanisms of molecular signaling, genetic associations with
disease pathology, and therapeutic developments. The biennial NOX Gordon Conference is firmly established
as the premier forum for the presentation and discussion of the latest advances in the field in a highly collegial,
collaborative, and informal atmosphere. The program for the 2022 NOX GRC was developed around the theme
"NOX Enzymes from Host Defense to Cell Signaling and Metabolic Disease", seeking to integrate the NOX
research field with rapidly emerging research areas of redox signaling and metabolism. The 2022 NOX GRC
Chair (Albert van der Vliet, University Vermont, USA) and Vice-Chair (Marie-Jose Stasia, University Grenoble
Alpes, France), along with the 2022 NOX GRS Chairs (Dina Vara and Carmen Veith), have solicited extensive
input from a Program Advisory Committee composed of 14 prominent NOX investigators and through informal
communications to cover the most exciting new developments and expand the program scope. The meeting will
start with a Keynote Session that addresses the discovery and evolution of the NOX enzymes and their general
role in redox biology, followed by 8 cutting-edge sessions that will address specific aspects of NOX biochemistry
and biology, including NOX structural biology, novel tools to study NOX function and regulation, new
developments in NOX-based cell signaling, interactions with cell metabolism, and the impact of NOX enzymes
on antiviral host defense and immune regulation, cell differentiation/stem cell function, and disease pathology.
Sessions include 36% female speakers/discussion leaders and 26% junior faculty. Up to 12 short talks will be
selected from submitted abstracts to accommodate cutting-edge late-breaking scientific advances and provide
speaking opportunities for new investigators. We expect exciting, state-of-the-art presentations, along with ample
time for vigorous discussion. Poster sessions will allow extended discussion and active involvement of trainees
in a friendly, supportive and informal atmosphere, and will be promoted by newly included elevator-pitch style
poster preview sessions. The GRS program features speakers selected from trainee abstracts, and career
development/mentoring components mediated by senior scientists.

Public health relevance
Project Narrative The Gordon Research Conference on NOX Family NADPH Oxidases and the preceding Gordon Research Seminar will bring together international experts, junior investigators and trainees in from diverse but complementary scientific disciplines relevant to the study of the NOX family of enzymes. Essentially all cell types in the body express NOX enzymes and they are being implicated in numerous diseases, including infectious/immune disease, cancer, cardiovascular and metabolic diseases, chronic inflammation, central nervous system, as well as childhood and rare diseases. The conference will attract a diverse group of male and female trainees, students and junior investigators in a highly collegial and interactive atmosphere and will expand our understanding of the mechanisms by which NOX enzymes contribute to different diseases and how novel therapeutics may be developed.